EFFECTS OF MILD HYPOGLYCEMIA ON CEREBRAL BLOOD FLOW IN CHILDREN WITH IDDM

Mild hypoglycemia causes a compensatory increase in rCBF in children who maintain normal cognitive ability whereas no change in rCBF, or even a reduction in rCBF will be seen in children who manifest cognitive impairment.